Research Core

PROJECT SUMMARY – RESEARCH CORE (Grenier)
The primary objective of the Research Core is to provide access to high quality, state-of-the-art, efficient and
cost-effective genomics technologies, as well as acting as a data integration hub for the Cornell ME/CFS
Collaborative Research Center. Maintaining the highest quality of technical and analytical standards is key to
generating the most usable datasets, particularly for complex disease states such as ME/CFS and for multi-
modal projects with a variety of sample types, assay types, and readouts. The Research Core will manage
genomics projects and provide services from the Transcriptional Regulation and Expression Facility and the
Genomics Innovation Hub in the Cornell Biotechnology Resource Center. As the data hub of the Cornell
ME/CFS Center, the Research Core will integrate de-identified patient demographic and clinical information
with processed data from all Projects into a centralized database, and will build custom software tools for
complex and dynamic queries, filters, and visualizations to enable data mining and discovery.